Cannabis use frequency and its impact on monocyte-mediated inflammation in HIV patients

PROJECT SUMMARY/ABSTRACT
An estimated 37 million people worldwide are infected with human immunodeficiency virus (HIV). Combined
antiretroviral therapy (ART) has turned HIV into a chronic infection with significantly longer life expectancy.
New health issues have surfaced as HIV patients live longer. Specifically, 50% of HIV-infected (HIV+)
individuals exhibit neurocognitive impairment, termed HIV-associated neurocognitive disorder (HAND). A key
event leading to HAND is persistent low-level chronic inflammation resulting in neuronal damage and cell
death. A major contributor to HIV-induced neuroinflammation is activated monocytes, which are significantly
elevated in patients’ with HIV-associated dementia (HAD). A hallmark of HIV infection is chronic, systemic
inflammation in part through translocation of microbial derived products from the gut which, activates
monocytes and promote migration across the blood-brain barrier (BBB). Upon entry, activated monocytes
release neurotoxic and proinflammatory factors (e.g., IL-1), which are thought to contribute to HAND.
Recently, evidence has emerged implicating the importance of inflammasome activation as a contributing
mechanism to neuroinflammation and HAND. Preliminary results presented in this application show that
inflammasome activation in monocytes, as evidenced by IL-1 secretion, promotes astroglial cell inflammation.
These findings support a critical role for inflammasome activation in monocytes as a mechanism driving
neuroinflammation. In particular, immunohistocytochemistry of brain tissue from post-mortem HIV patients with
HAD showed significant infiltration of proinflammatory CD16+ monocytes. By contrast, cannabinoid exposure
displays anti-inflammatory properties in HIV-infected patients, which we and others have reported. The anti-
inflammatory properties of cannabis are attributed largely to the canonical ligand, ∆9-tetrahydrocannabinol
(THC), which exerts psychotropic activity through cannabinoid receptor (CB) 1 and the non-psychotropic-
mediating CB2, while cannabidiol (CBD) does not act through CB1/CB2. Likewise, the CB2 selective agonist,
JWH-015, represents a potential strategy for understanding the role of CB2 in limiting HIV-associated
neuroinflammation. In fact, preliminary results demonstrate that a CB2 selective agonist impairs monocyte
secretion of IL-1, a hallmark of inflammation and inflammasome activation. Mechanistic studies are proposed
to test the hypothesis: CD16+ monocytes from non-cannabis using HIV+ subjects exhibit greater
inflammasome formation and subsequent astrocyte activation compared to cannabis using HIV+ subjects,
which is associated with the frequency of cannabis use.

Public health relevance
NARRATIVE This project investigates the effects of cannabis, and specifically the frequency of cannabis use, on HIV associated inflammation and how it relates to HIV-associated neurocognitive disorder.